Using the Genetic Architecture of Substance Use Disorders to Advance Gene Identification and Understanding of Pathways of Risk

Project Summary
This administrative supplement, submitted in response to NOT-DA-24-003 Rapid Translation of Substance Use
and Addiction Epidemiology and Prevention Intervention Research, proposes to translate the findings
emerging from the parent project R01DA050721 “Using the genetic architecture of substance use disorders to
advance gene identification and understanding of pathways of risk” to study the application of our genetic
epidemiological findings as a novel prevention intervention to reduce risky patterns of substance use among
emerging adults. The parent project has two complementary goals: (1) to advance discovery of genes involved
in substance use disorders using new multivariate genomic techniques, and (2) to characterize the risk
associated with identified variants in diverse longitudinal samples, across development, and in conjunction with
the environment. We have made tremendous advances in gene identification since the initiation of the parent
R01, with the results from our most recent genome-wide association study accounting for ~10% of the variance
in substance use and related outcomes in independent samples. We have integrated the resulting polygenic
scores with epidemiological information on behavioral and environmental risk factors, using data from multiple
diverse longitudinal cohorts, to create individual risk estimates, finding that the combination of epidemiological
risk information and genetic data meaningfully contribute to predicting who is at elevated risk of substance use
disorders in emerging adulthood. The rationale for this line of work is that it will lay the foundation for
personalized medicine, with the provision of personalized risk information helping prevent the development of
problems and/or allow for earlier intervention. With administrative funds from this supplement, we propose to
(Aim 1) create a new prevention/intervention program, consisting of an on-line platform for individuals to
receive their personalized risk estimates for addiction risk, generated by integrating information about their
genetic, behavioral, and environmental risk factors based on research from the parent grant, followed by
information about how to reduce risk, developed with the addition of new collaborators with expertise in
behavior change; and (Aim 2) conduct a small RCT (N=400) with emerging adults (18-25yrs), who are entering
the high-risk period for escalation of risky substance use and the development of problems, to test whether
completion of the personalized feedback program is associated with reductions in risky substance use. This
project represents a critical first step in translating genetic epidemiological findings to prevention intervention.

Public health relevance
Project Narrative A founding principle of precision medicine is that the provision of personalized risk information, created by combining genetic, behavioral, and environmental data, will help prevent the development of problems and/or allow for earlier intervention. Substance use disorders are a model test case in which to explore important translational questions about the application of genetic epidemiological research to prevention/intervention, as individuals who are at elevated risk can proactively prevent the development of problems by terminating or reducing substance use. This administrative supplement will apply genetic epidemiological findings to develop a new prevention/intervention program and test the extent to which the provision of personalized risk information helps individuals reduce substance use.